CORE--RESEARCH DEVELOPMENT

SPECIFIC AIMS To enable rapid pursuit of innovative research by support of pilot projects in the Basic Biology of Aging. These awards will also be used to assist junior faculty career development and the recruitment of senior faculty not previously involved in aging research to the field of the biology of aging.